PDX Trial Center for Breast Cancer Therapy

Project Summary
The scientific premise of this Center is that breast cancer patient-derived xenograft (PDX) and organoid models
represent the diversity of human breast tumors, and can be feasibly utilized to test new drugs and drug
combinations to find therapeutic approaches that match with molecular features of various tumor types. Our
PDTC is focused on identifying new treatment strategies for breast cancer, which remains the 2nd leading cause
of cancer death in women. We will conduct preclinical evaluation of drugs and drug combinations in models
selected from our large collection of 261 breast PDX models and >100 stable PDxO lines representing primary,
metastatic, and treatment-resistant breast cancers from diverse patient populations (25% of the collection is from
racial/ethnic minorities, with plans to increase that proportion in Aim 1 of both research projects). The Center
comprises two highly integrated Research Projects that are designed together to combat the two most difficult
problems contributing to breast cancer deaths: breast cancer recurrence, and treatment of recurrent/metastatic
disease. More than 90% of breast cancer deaths are attributed to disease recurrence as incurable metastatic disease.
Project 1 is focused on improving therapy for early-stage triple negative breast cancer (TNBC), to prevent
recurrence and achieve durable cures by identifying optimal chemotherapy and targeted therapy combinations
based on molecular features of tumors. Project 2 aims to identify more effective regimens in disease that does
recur (treatment-resistant, metastatic disease) by utilizing our unique collection of PDX and PDxO from
metastatic samples. These two complementary research projects will be supported by a PDX Core, a
Bioinformatics Core, a Pilot Projects and Trans-Network Activities Core that fosters exploration of new ideas
within the PDTC and in collaboration with the PDXNetwork (PDXNet), and an Administrative Core that provides
project oversight and management, and facilitates effective communication within the PDTC and the PDXNet.
The overarching goal of our PDX Development and Trials Center (PDTC) is to obtain preclinical data that will
facilitate prioritization of drugs to be tested in breast cancer clinical trials at the National Cancer Institute (NCI).

Public health relevance
Project Narrative The scientific premise of this Center is that breast cancer patient-derived xenograft (PDX) models represent the diversity of human breast tumors, and can be feasibly utilized to test new drugs and drug combinations to find therapeutic approaches that match with molecular features of various tumor types. The goal of our PDX Development and Trials Center (PDTC) is to obtain preclinical data that will facilitate prioritization of drugs to be tested in clinical trials at the National Cancer Institute (NCI). Toward this goal, our PDTC focuses on testing drugs that are already available through the NCI as NCI-IND agents with the Experimental Therapeutics Clinical Trials Network (ETCTN).